Aminopeptidases for Neurotoxic Pyroglutamate Beta-Amyloid of Alzheimers Disease

DESCRIPTION (provided by applicant): The N-terminal truncated pyroglutamate (pGlu) modified forms of beta-amyloid (A β), pGluA β (3-40/42) (referred to as pGluA β), display high neurotoxicity, neurodegeneration and memory loss in Alzheimer's disease. Notably, pGluA β is abundant in AD brains and is present at levels greater than Aβ (1-40/42). The pGluA β accelerates formation of Aβ and pGluA β oligomers that cause neurotoxic cell death and memory deficits in AD. The pGluA β (3-40/42) peptides begin with N-terminal glutamate, the third amino acid of Aβ (1-40/42). pGluAβ peptides are generated from A β (1-40/42) by aminopeptidases that remove the N-terminal aspartate and alanine residues, followed by cyclization of the N-terminal glutamate. The aminopeptidases required to generate pGluAβ peptides have not yet been elucidated. Therefore, the goal of this project will be to identify the aminopeptidase mechanisms responsible for generating neurotoxic pGluAβ that participates with A β in development of AD. Results can provide novel protease targets for Alzheimer's disease. The hypothesis of this project is that the aspartate aminopeptidase and alanine aminopeptidase enzymes generate A β (3-40/42) which is converted to pGluAβ(3-40/42) by glutaminyl cyclase (QC). This hypothesis is supported by our preliminary data demonstrating the presence of aspartate and alanine aminopeptidase activities in secretory vesicles that contain pGluAβ (3-40/42) and Aβ (1-40/42). This hypothesis will be assessed in three specific aims to (1) identify aspartate and alanine aminopeptidases in A β -producing secretory vesicles that remove the N-terminal Asp and Ala residues from A β (1-40/42), (2) evaluate identified aminopeptidases by gene silencing and expression for their roles in producing pGluAβ (3-40/42), and (3) evaluate inhibitors of these aminopeptidase activities to reduce production of pGluAβ (3- 40/42). This project will identify new aminopeptidase mechanisms for producing neurotoxic pGluAβ peptides. Results will also yield candidate inhibitors of these aminopeptidases for future investigation of aminopeptidase regulation in Alzheimer's disease.

Public health relevance
Alzheimer's disease (AD) involves production of neurotoxic β -amyloid peptides that participate in the development of memory deficits in the disease. This project will identify the aminopeptidase protease mechanisms that produce neurotoxic pGlu-beta-amyloid peptides forms that participate in memory loss and amyloid plaques of AD. Results can provide new drug targets to address the unmet need for development of therapeutic agents to treat Alzheimer's disease.